Methods Training for Comparative Effectiveness Research in Cancer

Comparative effectiveness research (CER) aims to inform healthcare decisions by providing evidence on the
benefits and harms of different alternatives in cancer care. While randomized controlled trials are often
considered to be the gold standard of research and have high internal validity due to their controlled
environment, they are often not generalizable to `real-world' populations. Clinical trials often exclude large
segments of the population, particularly those who are older or have comorbid conditions, threatening the
external validity of the findings. Furthermore, explanatory trials typically compare only two or three
interventions. As the number of cancer therapies and technologies increases exponentially, additional methods
are necessary to adequately compare benefits and harms across several different interventions. While the
emphasis in the past was on determining whether an intervention could work under the best conditions,
increasing importance is given to whether interventions also work in `real-world' settings, and how they
compare to other available alternatives. Real-world evidence and CER are vital to adequately evaluate and
position new health interventions and technologies as they emerge. Few training programs specifically address
CER methodologies. The overarching goal of this application is to implement a comprehensive national CER
training program for junior cancer investigators, encompassing the broad spectrum of healthcare delivery in
cancer care. Training will encompass three major CER methodologies: 1) Knowledge synthesis including
systematic reviews, meta-analysis, and decision analysis; 2) Observational studies and secondary data
analysis of registries and other sources of data, and 3) Pragmatic clinical trials, and. After first completing a
series of interactive online courses in these topics to acquire a strong knowledge base in CER, participants will
complete an intensive, hands-on training small group workshop in one or more of the three CER
methodologies. Each participant will develop an individual protocol for a CER study, for a research question of
their interest. Topics of interest can address any of the stages of care throughout the cancer continuum,
including prevention, screening, diagnosis, treatment, supportive care, end-of-life care, and survivorship.
Program faculty will provide individual methods guidance and support to participants during the 12 months
after enrolling in the course. Participants will be junior investigators, recruited nationally, and affiliated with
academic institutions, cancer centers or non-profit organizations (junior faculty, research scientists or post-
doctoral or clinical fellows with an expectation of a research career path). Enrollment methods will include
engaging underrepresented minorities. This education program is designed to support the National Cancer
Institute's educational mission by arming cancer researchers with innovative tools needed to conduct CER.
Expanding CER in cancer research will lead to robust real-world evidence, which can inform cancer patients,
caregivers, providers and policy-makers of the benefits and harms of cancer treatment options.

Public health relevance
PROJECT NARRATIVE The goal of this program is to increase the number of cancer researchers conducting comparative effectiveness research (CER) at the national level. The proposed intensive curriculum will provide program participants with a strong foundation in CER, and the knowledge and skills to design and conduct CER studies including ‘real-world’ observational studies, pragmatic clinical trials and knowledge synthesis. The program will benefit public health by advancing the use of comparative evidence, which can inform cancer patients, caregivers and providers of the benefits and harms of alternative healthcare options and provide value-based care that can extend the length and quality of life of cancer patients.